Ophthalmic Genetics Fellowship

The stated clinical duties of an ophthalmic genetics fellow are:

1) Assisting in the work-up of ophthalmic genetics patients, including taking of pertinent medical and family history and ophthalmic examination. The fellow is expected to work at least one day a week with each of the clinical attendings in the OGVFB (Dr. Cathy Cukras, Dr. Wadih Zein, Dr. Laryssa Huryn, Dr. Brian Brooks and Dr. Robert Hufnagel). One day a week is reserved for academic and administrative duties.

2) Obtain a working knowledge of clinical and molecular genetics. This will be accomplished by formal coursework in FAES (the GENES 500 series and other supplemental course work), hands-on training in the clinic with physicians and genetic counselors, and in the molecular diagnostic laboratory. It is expected that at the end of the training, the fellow will be able to collect a three generation pedigree, understand the basics of a clinical genetics evaluation, and have a working knowledge of molecular diagnostics.

3) Become proficient in the examination and treatment of ophthalmic genetics patients. This will include the performing of electrodiagnostics (ERGs, multifocal ERGs, VEPs) and psychophysical testing (Goldmann perimetry and dark adaptation).

4) Perform a clinical or basic science research project of his/her choosing, with the approval of the fellowship director.

5) Present regularly at Friday morning and/or Wednesday afternoon conferences, as assigned by the fellowship director. The formats will include patient presentations, literature reviews, and/or journal clubs.

6) Assist in the preparation and writing of manuscripts for publication

7) Assist in the preparation and writing of clinical protocols

Dr. Dimopoulos completed his Ophthalmic Genetics Fellowship in July 2023 and a new research Ophthalmic Genetics Fellow has joined in this review period. Fellows have been exposed to a wide variety of inherited eye diseases including retinitis pigmentosa, Stargardt disease, achromatopsia, Leber congenital amaurosis, coloboma, microphthalmia, anophthalmia, aniridia, WAGR, holoprosencephaly, cystinosis, Usher syndrome, neurofibromatosis type 2, albinism, xeroderma pigmentosum, trichothiodystrophy, and Bardet-Biedl syndrome. In addition, we have been active participants in the NIH-wide Undiagnosed Disease Network.